IL17 Signaling in Monogenic Type 1 Diabetes

Project Summary/Abstract
This proposal’s objective is to determine whether genetic mutations that alter IL-17 signaling contribute to the
etiology of autoimmune diabetes. Autoimmune diabetes is characterized by circulating autoantibodies and
infiltrating autoreactive lymphocytes into the pancreatic islet, eventually leading to β-cell failure and death.
Studies of individuals and families with suspected monogenic forms of autoimmune diabetes provide a unique
opportunity to understand novel pathways in human biology. For example, type 1 diabetes (T1D) is a frequent
feature in patients with deleterious mutations in AIRE and FOXP3. Dissecting the consequences of these
mutations has improved our understanding of the mechanisms underlying immune tolerance and how
perturbations to these mechanisms results in organ-specific autoimmune disease, such as T1D. Over the last
decade, rapid advances in genetic sequencing have allowed for a deeper exploration and discovery of rare
variants that are linked to disease with techniques like whole exome sequencing. Using this approach in both
kindreds and rare outlier patient populations, there has been expanding discovery of mutations in other
pathways with a link to T1D that include CTLA4, LRBA, STAT1 and STAT3. We identified families with
multigenerational type 1 diabetes and candidate mutations in IL17RC and IL17C. These mutations were not
found in more than 270,000 alleles in the Genome Aggregation Database (gnomAD) database and have a
CADD score (“Combined Annotation Dependent Depletion”, a widely used tool for predicting the
deleteriousness of single nucleotide variants) of >20, which places these in the top 0.5% of deleterious
mutations in humans. Our preliminary data suggest that these are gain-of-function mutations and that their
constitutive activity results in autocrine inflammatory signaling loop in pancreatic β cells. We propose to test
this model using both in vitro and in vivo approaches. If successful, these studies will enable us to understand
the mechanism by which altered IL-17 signaling leads to autoimmune diabetes.

Public health relevance
Project Narrative Autoimmune disease affects 41 million Americans and rising. This genetic study focuses on discovering mutations in the protein coding region of the human genome that increase the risk for autoimmune disease, which are, by default, biological targets for treatment. The results from this study will enable better detection, prediction, and treatment for patients with autoimmune disorders.